Role of novel VTA neurons in addiction-related behaviors

PROJECT SUMMARY
The ventral tegmental area (VTA) is a core component of the neural circuitry that drives goal-directed
behaviors and a primary target of drugs of abuse. Although generally regarded as a dopaminergic
nucleus, many VTA neurons can signal through release of the neurotransmitters GABA and glutamate.
These neurons are also targets of drugs of abuse but much less studied. Like VTA dopamine neurons,
activity in VTA GABA and glutamate neurons can profoundly shape motivated behaviors. Furthermore,
sub-populations of VTA neurons release more than one of these recycling transmitters, including
neurons that co-release dopamine and glutamate, or glutamate and GABA. A major goal of this
proposal is to identify how these three major transmitters released from VTA act on postsynaptic
neurons to alter behavioral reinforcement. And to assess the contribution of non-dopamine VTA
projection neurons and inputs to VTA in opioid-induced behaviors.

Public health relevance
PROJECT NARRATIVE A better understanding of the neural circuitry that control motivated behavior is critical to developing new strategies to treat and prevent drug addicition and other compulsive disorders. Dopamine neurons in the ventral tegmental area (VTA) have been widely implicated as a common substrate of drugs of abuse, but other VTA neuron types also contribute and may represent new targets for future intervention. This research program will evaluate the contribution of novel VTA populations to behavioral reinforcement and opioid-induced behaviors.